Administrative Core

SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core will support the translational research objectives of the Memorial Sloan Kettering Cancer
Center (MSK) Pancreas SPORE by providing: (1) centralized administrative support of the daily activities of the
SPORE Program, and (2) coordination for all educational and scientific activities of the SPORE, including three
research projects, two cores, a Developmental Research Program (DRP), and a Career Enhancement Program
(CEP). This work will be performed under the direction of the SPORE Principal Investigators, Christine Iacobuzio-
Donahue, MD, PhD, and Eileen M. O’Reilly, MD, who will share overall authority for the scientific and
administrative decision-making. The Administrative Core will also include a team of experienced personnel
trained in financial management, operations, grants administration, medical editing, and data management.
Administrative Core members will work as a team to ensure the effective financial and administrative
management of the SPORE. The Administrative Core will be responsible for financial management, submission
of all reports and non-competing renewal applications to the NIH/NCI, coordination of the DRP and CEP, and
coordination of meetings for consistent scientific review of ongoing SPORE research. The Core will also be
responsible for annual solicitation of new applications for the DRP and CEP, as well as fostering communication
and collaborative research within our SPORE, with other SPOREs in Pancreas or Gastrointestinal Cancers and
the wider scientific community, and sharing genomic and other molecular data and linked clinical annotation in
a manner that assures patient privacy and compliance with all Federal and State regulations. The centralized
services of the Administrative Core will ensure the effective financial and administrative management of the
SPORE.

Public health relevance
NARRATIVE Not applicable.